Leveraging whole genome sequencing and functional genomic characterization to improve NSCLP gene discovery

PROJECT SUMMARY
NSCLP is a common birth defect affecting ~135,000 newborns/year worldwide. The etiology is complex with
genetic and environmental factors, and their interactions all playing roles. It is estimated that only ~25% of the
genetic liability for NSCLP has been uncovered with most of the identified variants reflecting common, modest
risk-variants often located in noncoding regions of the genome. Despite advances in NSCLP gene discovery,
the specific effects on biological signaling networks for most variants are largely unknown and a challenge
remains on recognizing which of these variations have functional effects on the phenotype. Recently, we and
others have shown that part of the missing heritability for NSCLP lies in rare, high-risk variants potentially
interacting with common variants. Further, our work confirmed polygenic inheritance for NSCLP which may
explain part of the missing heritability and the variable phenotypes observed within families. These observations
highlight the complexity of NSCLP and difficulty in unraveling risk alleles and may explain the lack of consistent
findings among studies. Through an X01DE031445 from the Gabriella Miller Kids First (GMKF) Program, we
have obtained whole genome sequencing (WGS) data for 172 large and well-characterized multigenerational
families of Hispanic and nonHispanic white ethnicities. In this proposal, we leverage detailed phenotypic data
and high-quality WGS data from our multigenerational NSCLP families, additional GMKF NSCLP datasets, and
the All of Us program to systematically evaluate and validate the contributions of common and rare variants to
NSCLP, and functionally characterize prioritized variants in vitro and in vivo. Specifically, we will (1) integrate
gene- and variant-based linkage and case-control association analyses, as well as polygenic risk score (PRS)-
informed analyses to determine the genetic architecture underlying familial NSCLP, (2) perform functionally-
oriented analysis for screening prioritized variants using cell-based assays, and (3) determine the impact of
prioritized variants on phenotypic changes in zebrafish embryos. This proposal overcomes the limitations of
previous studies by providing a paradigm for advancing knowledge of the underlying biological mechanisms
leading to NSCLP through the use of large and well-characterized NSCLP and control datasets and rigorous
methodologies for gene discovery with validation, and functional genomic characterization in vitro and in vivo.
The results will allow us to identify complex inheritance patterns contributing to the genetic etiology of NSCLP
and inform additional mechanistic studies that will provide the groundwork for improved risk assessment and
translation into more precise genetic counseling in clinical practice. Our proposal meets the goals of PAR-21-
229 as it addresses a challenging gap between identifying sequence variations of potential interest and
recognizing which of those variations have functional effects on NSCLP.

Public health relevance
PROJECT NARRATIVE Nonsyndromic cleft lip with or without cleft palate (NSCLP) is a common birth defect that imposes significant medical, financial and psychological burdens, reducing the quality of life. Genetic variation in numerous genes has been associated with NSCLP, however the exact mechanisms by which they contribute to the condition remain largely unknown. This study will analyze whole genome sequencing data from large and well characterized NSCLP family datasets to assess the contribution of rare and common variants to NSCLP and characterize the function of identified variants.